Neural mechanisms of gait disturbances as individualized digital biomarker trajectories in preclinical dementia

PROJECT SUMMARY
Alzheimer's disease and related dementias (AD/ADRD) rank prominently among age-associated
neurodegenerative disorders, with Parkinson’s disease trailing as the second most common. Contemporary
studies on AD and Mild Cognitive Impairment (MCI) have unveiled cognitive decline indicators mirrored in
nuances within gait and hand movements. These indications often emerge long before AD or MCI diagnoses
are confirmed. Consistently, research has correlated slowed gait with cognitive deterioration, elevated brain
amyloid levels, and an augmented AD risk. However, the interplay between systems influencing both cognition
and movement has largely been explored in separate studies. The depth of understanding around the cognitive
efforts required for gait initiation or motor planning remains scant. Though dementia screening traditionally
hinges on comprehensive neuropsychological evaluations and neuroimaging biomarker studies, gait and
movement assessment offers a more direct approach. Crucially, motor features remain unaffected by
language, educational background, or cognitive capabilities, positioning them as unbiased and consistent
evaluative instruments. For example, the Short Physical Performance Battery (SPPB) tests can be easily
conducted at home and monitored, even using smartphone applications. In this project, we chart a course to
harness cutting-edge AI and computer vision (CV) tools to aid in distinguishing diverse dementia and MCI
subtypes, such as AD-related MCI versus MCI with PD pathologies. Our approach integrates multi-modal brain
imaging with gait and movement data from videos, aiming to extract nuanced markers for phenotyping
(pre)clinical AD. These markers can then serve as precise digital trackers for both the progression and
distinction of age-related degenerative disorders. Ultimately, we aspire to enhance the understanding of the
intricate links between gait, movement, and cognition in aging and AD/ADRD scenarios.

Public health relevance
PROJECT NARRATIVE In this project, we uncover the neural mechanisms of gait and mobility disturbances in preclinical dementia and identify trackable individualized digital biomarkers (from videos). We evaluate the specificity and sensitivity of these gait-based biomarkers and relate those to neural mechanisms and clinical phenotypes. By leveraging these identified markers, we can monitor the disease's progression, potentially minimizing or even replacing the demand for expensive neuropsychological or neuroimaging evaluations.